Development of a generalizable chemo-proteomics screening platform for small molecule degraders applied to HDACs

Project Summary
Targeted protein degradation with small molecule degraders is an emerging therapeutic modality for cancer
treatment. Degraders have several advantages compared with traditional inhibitor drugs that make them
attractive new therapeutic entities. First, degraders can work at much lower concentration than inhibitors, thus
can be used at lower dosage and have lower drug toxicity. Second, degraders remove the target protein
altogether rather than simply inhibiting the enzymatic activity of the protein, thus eliminating the non-enzymatic
activities of target proteins. Such non-enzymatic activities are especially common for histone deacetylases
(HDACs). Third, degraders can be used to target targets considered “undruggable” by conventional means,
which represent 80% of the human proteome, as long as a protein binding ligand is available. However, the
current strategies to develop degraders follow a rather empirical route with fortuitous outcomes. Here we propose
to develop a new screening platform to discover and develop degrader molecules. The strategy involves
structure guided degrader library design based on promiscuous inhibitors that target a protein family followed by
chemo-proteomics screening to identify degradable protein family members and selective degraders against
them. The large amount of data from proteomics screens enables us to understand the relationship between the
chemical structures of degraders and potency of target protein degradation, which feeds back to the next round
of iterative library design and screening. Such iterative rounds of optimization with proteomics evaluation have
proven to be a more effective way to generate selective and potent degraders for developing therapeutic
candidates and chemical probes for biological studies. We apply this strategy to an important family of enzymes,
HDACs, for which specific inhibitors are rarely available. HDACs are therapeutic targets for many different kinds
of cancer and human diseases. We propose to develop selective degraders for a number of HDAC members.
Particularly, we hope to develop HDAC8 degraders as a new therapeutic candidate for Ewing sarcoma, an
aggressive cancer in children and young adults that have an urgent need for new therapeutic options. Secondly,
we hope to develop selective HDAC6 degraders to test the proposed role of HDAC6 in inflammasome activation.
We believe this strategy is widely applicable to other protein families and would make a significant impact in the
field of developing degrader therapeutics.

Public health relevance
Project Narrative We propose to develop a new strategy to develop small molecule degrader drugs, a new therapeutic regiment for cancer treatment that greatly expands the range of drug targets beyond what is accessible to more traditional inhibitors. We expect this to have a profound impact on cancer drug discovery and human health.